Development of Standardized Electronic Treatment Plan Builds for NCI-Supported Clinical Trials Applicable Across Clinical Research Sites; In conjunction with the Big Ten EHR Consortium-Year 2

Project Summary-Abstract Not required per special announcement notice

Public health relevance
Project Narrative Not required per special announcement notice